Cas9 RNP targeting cis-regulatory elements in lymphocytes

Project Summary
CRISPR tools for genome editing have revolutionized and accelerated the functional interrogation of coding
genes in model animal systems and in human somatic cells, including primary lymphocytes that play critical
roles in the immunopathology of allergy and asthma. We propose to adapt and optimize these tools for miRNA-
directed pathway discovery. First, will create pooled retroviral CRISPR libraries for targets that we have
empirically identified for miR-29, a miRNA with critical functions in both T cells and B cells. Second, we will
extend next generation transfection-based CRISPR systems to target cis-regulatory sequences that do not
code for protein, but mediate regulatory interactions between miRNAs and target mRNAs. Success in these
aims will enable detailed mechanistic analysis of miRNA:target networks that govern immune responses in
asthma and allergy. A second important goal of this proposal is to support the career and scientific
development of Celeste Garza, a post-baccalaureate researcher gaining research experience as a junior
specialist in the Ansel laboratory. The proposed experiments build on skills she has learned in the Ansel lab,
and will provide the opportunity for her to develop a research narrative and scientific achievements as prepares
to apply for PhD programs in the coming year.

Public health relevance
Project Narrative We propose to develop and optimize genome editing tools for the investigation of genetic networks and molecular mechanisms that govern immune responses. If successful, this work will propel our ongoing research on the causes of allergy and asthma. It will also provide an opportunity for the career and scientific development of post-baccalaureate researcher Celeste Garza.